Engaging reticulospinal inputs to improve walking

Abstract
Locomotor recovery is one of the most important goals of individuals with spinal cord injury (SCI). Ambulatory
deficits severely impact daily functions resulting in lower quality of life for people living with paralysis due to SCI.
Although studies have shown that locomotor training improves locomotor function in people with chronic SCI,
the benefits remain limited. Our overall hypothesis is that we can engage additional descending motor pathways,
such as the reticulospinal tract (RST), to improve locomotor function in humans with chronic incomplete SCI.
The goals of this proposal are: (1) Examine the contribution of the RST to lower limb muscles during locomotion,
and (2) to combine non-invasive paired RST activation and electrical muscle stimulation with treadmill training
to improve motor output in individuals with chronic incomplete SCI.
In Aim 1, we propose to measure the effects of a loud auditory stimulus to engage the RST on the amplitude and
latency of electromyographic responses in multiple lower limb muscles such as the quadriceps femoris,
hamstrings, soleus, and tibialis anterior bilaterally during locomotion in individuals with and without SCI. In Aim
2, we propose to test the effects of a novel intervention that uses repeated paired loud auditory and electrical
stimulation of muscle afferents combined with locomotor training on walking speed and voluntary muscle
strength. Here, individuals with chronic incomplete SCI will be randomly assigned to a group that will receive 10
sessions of a startle stimulus and electrical stimulation combined with locomotor training or 10 sessions of a non-
startle stimulus combined with locomotor training.
Taken together, the results of these studies will provide fundamental information about the contributions of the
RST to locomotion in humans with and without SCI and will furthermore open novel avenues for improving
locomotor function in individuals living with paralysis due to SCI.

Public health relevance
Project Narrative: Current locomotor training programs result in limited improvements in walking ability in individuals with chronic incomplete spinal cord injury (SCI). Here, we propose to assess the contribution of the reticulospinal tract (RST), a major but largely under investigated descending motor tract in humans, to the control of lower limb muscles during locomotion and to apply a novel paradigm aiming to engage RST projections to lower limb muscles in combination with locomotor training to improve walking ability in individuals with chronic SCI. The results of this work will contribute to understand RST contributions to lower limb muscles and might contribute to developing new non-invasive techniques to improve locomotor function in individuals living with SCI.